SPROUTS - CHILD AGES 6 AND 7 YEARS

The government has a need to establish a cohort study, leveraging on existing historical data from the PEAS ongoing study, to recruit mother-child dyads and collect baseline information. Establishing this framework is critical to the successful recruitment of participants and data collection. Maternal neurobehavioral factors, pregnancy diet quality, gestational weight gain, early life maternal feeding practices, infant eating behavior, and exposure to discretionary foods were obtained in PEAS at multiple time points during pregnancy through one year postpartum. Data collected during this task order (TO3) will include child attentional bias to food cues, food acceptance, food reinforcement, and anthropometrics. Child eating behaviors, food intake, parent fe ding practices, home food environment, and anthropometrics will be obtained from mothers.